Coordination mechanisms between cell division and chromosome segregation in E. coli

PROJECT SUMMARY
The goal of this proposal is to provide a mechanistic understanding of how cell division in bacteria is controlled
at a molecular level. Understanding these mechanisms, which are broadly conserved among the bacteria, is
important because it can reveal potential targets for new antibacterial agents that inhibit cell division and stop
cell propagation. The division process in bacteria involves two stages. In the first distinct step, FtsZ protofilament
assembly, the Z-ring, forms. In Escherichia coli, the model organism for this study, the first step occurs early in
the cell cycle. Only after a significant delay, which can last half of the cell cycle, does the second stage of cell
division start. In this later step, septal peptidoglycan synthesis begins, and the cell constricts. In this stage, more
than two dozen proteins are involved, most of them in a complex referred to as the divisome. It is not yet
understood what determines the onset of either the first or the second stage of the division, both of which are
critical for the cell's survival. This significant gap in our knowledge exists even though many proteins involved in
cell division are known and their pairwise binding interactions mapped out. The difficulty in understanding
processes controlling cell division arises from the presence of a large number of different interactions within the
divisome and of many pathways that are partially redundant. Moreover, the protein assemblies, which in most
studies are viewed as static, are highly dynamic, turning over in a matter of seconds in an energy-dependent
process such as treadmilling. The complexity of the problem requires not only further experiments but the
integration of the existing experimental results into a comprehensive modeling framework. Accordingly, we
combine state-of-the-art experimental methods with stochastic cell cycle simulations and 3D modeling of
assembly reactions of proteins involved in cell division. On the latter front, we leverage our previous work and
ongoing collaborations. In the experimental work, we use molecular biology and genetic methods alongside high
throughput and super-resolution microscopy, and we develop novel microfluidic devices for this research. These
techniques have already generated large amounts of information-rich data that, among other findings, have shed
new light on processes leading to the assembly of Z-ring from individual FtsZ protofilaments and determining the
role of DNA replication over the control of the progression of the second stage of the division. The proposed
work aims to consolidate these past findings into a single mechanistic framework. The knowledge gained will
enhance our understanding of fundamental cellular processes in bacteria and provide a basis for designing
effective antibacterial therapies that target bacterial cell division.

Public health relevance
PROJECT NARRATIVE Cell division is an essential process for a cell to produce viable progeny. The proposed research will provide a mechanistic understanding of the control mechanisms involved in the formation of bacterial Z-ring and triggering the onset of constriction. These molecular processes are potent targets for new antibacterial drugs.